CORRELATION OF REGIONAL CEREBRAL BLOOD FLOW WITH REM SLEEP EYE MOVEMENT COUNTS

This protocol is a study to determine whether the same cortical areas are involved in eye movements in both REM sleep and wakefulness using 15 Oxygen-PET measurements of rCBF and to collect dream reports after the completion of the last 15 O-PET scan for future studies to correlate rCBF with visual imagery and language in dreaming.